The role of the N-terminus of GATA1 in erythropoiesis

PROJECT SUMMARY
The zinc finger transcription factor GATA1 is essential for development of a subset of hematopoietic lineages,
including erythroid cells and megakaryocytes. Inherited mutations in GATA1 are associated with a spectrum of
hematopoietic disorders including dyserythropoietic anemia and thrombocytopenia, caused by mutations in the
N-terminal zinc finger, Diamond Blackfan Anemia (DBA), caused by mutations that lead to loss of the N-terminal
transactivation domain, and hemolytic anemia caused by mutations in an intrinsically disordered region. The
focus of this proposal is on understanding the consequences of loss of the N-terminal transactivation domain on
red cell development. The isoform that lacks the N-terminus is named GATA1 short, or GATA1s. Mice that mimic
these human mutations, Gata1s mice, display prominent defects in erythropoiesis in utero and a lifelong
macrocytic anemia that has some similarities to DBA. In our published and preliminary studies, we have found
that GATA1s binds chromatin to a similar extent as full length GATA1 but fails to lead to proper chromatin
accessibility or histone modifications. We hypothesize that the absence of key protein-protein interactions
between GATA1s and chromatin regulators such as SWI/SNF and NuRD complexes, leads to impaired gene
regulation. We performed single cell RNA-sequencing of E13.5 Gata1s fetal livers and identified prominent
changes in the erythroid lineage including relative increases in proerythroblasts and basophilic erythroblasts with
concomitant decreases in the polychromatic and orthochromatic stages. Within the basophilic and polychromatic
stages, we observed enrichment of pathways that control metabolism, including oxidative phosphorylation, in
the Gata1s mutant cells. We hypothesize that metabolic defects resulting from aberrant gene regulation by
GATA1s contributes to the defect in red cell maturation in mouse models and patients. In this grant, we propose
to: 1) Identify the cofactors that are recruited by the N-terminus to regulate erythropoiesis; and 2) Investigate the
role of the N-terminus in controlling erythroid gene expression and metabolism. These innovative studies will
increase our understand of how the N-terminus regulates transcription, metabolism, and erythroid maturation
and may shed light on strategies to improve erythropoiesis in DBA and other congenital anemias.

Public health relevance
PROJECT NARRATIVE GATA1 is a gene that is essential for red blood cell development, and mutations in GATA1 cause a spectrum of blood diseases in humans. In this proposal, we study the effect of one type of GATA1 mutations that lead to the loss of the N-terminal domain. We seek to define the function of this domain in red blood cell development and to understand how it controls metabolism and differentiation.